CRDF GLOBAL ACR FEES FOR MISC AND UICC COORDINATION WITH AJCC

As part of its long-standing support for international research programs of the National Institutes of Health (NIH), CRDF Global will provide project coordination, financial management and logistical support services for the National Cancer Institute's (NCI), Division of Cancer Control and Population Science (DCCPS). The funding for this activity has been transferred by NCI/DCCPS to NSF under interagency agreement APC21003-001-00001, and this document represents a formal request to transfer those funds from NSF to CRDF Global.
DCCPS aims to reduce risk, incidence, and deaths from cancer as well as enhance the quality of life for cancer survivors. The division conducts and supports an integrated program of the highest quality genetic, epidemiological, behavioral, social, applied, and surveillance cancer research. DCCPS-funded research aims to understand the causes and distribution of cancer in populations, support the development and delivery of effective interventions, and monitor and explain cancer trends in all segments of the population. Central to these activities is the process of synthesis and decision making that aids in evaluating what has been learned, identifying new priorities and strategies, and effectively applying research discoveries to reduce the cancer burden. This project is an ongoing effort to support capacity building, cancer control priorities, registry development, and training.
The three general categories of work required for financial and administrative logistics support from CRDF Global are:
1) Directed travel, lodging and other arrangements for conferences and workshops conducted in the US and abroad.
2) Directed payments to research and other specialist consultants and institutions in support of activities to manage on-going projects in cancer control, registry development, and training.
3) Directed workshop participant, grantee identification and funding support for cancer-related research and training, which includes, but is not limited to, developing calls for applications, coordinating peer review, and administering awards.